Modular Convertible Child Safety Seat to Improve Usage

Project Summary/Abstract
Minnesota HealthSolutions Corporation proposes to develop an innovative all-new convertible child safety seat.
Child safety seats are installed in vehicles by properly attaching and tensioning the main anchorage points. Proper
use of the attachments is extremely important as these significantly reduce child head injuries in motor vehicle
crashes. Attachments are inconveniently located on child safety seats and difficult to use. Several large studies
have observed that only 10% to 20% of children are correctly harnessed into correctly installed seats. Improper
use of child restraints substantially reduces their effectiveness and is a major public health concern. The
proposed child safety seat will be extremely easy-to-use and will dramatically increase the visibility and usability of
the attachments. We hypothesize that a child safety seat that provides a convenient, easy-to-use attachment will
significantly improve the rate of proper child safety seat usage and reduce vehicle crash-related child injuries and
deaths. An interdisciplinary team of researchers has been assembled to define, build, and evaluate a prototype
system. The production development will be completed in a rigorous quality-controlled design and testing process
to ensure a safe and effective product is produced.

Public health relevance
Project Narrative Motor vehicle crashes are the leading cause of unintentional morbidity and mortality among children in the United States and a leading cause of brain injury. From 2014 to 2018, 3,417 children ages 0 to 8 died as an occupant in a motor vehicle crash and 364,327 required hospital treatment for an injury. We aim to develop a significantly improved child safety seat to better protect children riding in motor vehicles.